Veterans Affairs Learning Opportunities in Research (VALOR)

The VALOR program will build upon the success of the pilot project attracting underrepresented interns to
consider a career in VA R&D. During the initial 2-year pilot project, 18 interns were supported. 83% of whom
were from underrepresented populations, and 27% reported an impairment that affected one or more activities
of daily living. The VALOR program embodies innovation and scholarly excellence through its convergence
science approach. The program's emphasis on collaboration and inclusivity fosters a dynamic learning
environment where diverse perspectives and disciplines converge to tackle complex challenges. For the next 5
years, we propose to target enrollment of 10 interns each year from underrepresented populations (targeting
recruitment of PWD, veterans, family members of veterans, and other underrepresented populations) interested
in VA biomedical engineering R&D. Interns in the VALOR program will be able to participate for up to two
summers to increase their exposure to VA R&D becoming more meaningfully engaged in R&D through
convergence teams. The duration of the internships will be 10-weeks, 40 hours/week, for 400 VA R&D contact
hours. The estimated time spent on R&D versus training/educational activities is 80% and 20% respectively.
VALOR program activities will center on five objectives: (1) developing a sense of excitement about VA R&D
activities and career opportunities; (2) human-centered technology and engineering though PADE; (4)
developing a critical thinking scientific mindset that promotes success in VA R&D, and (5) understanding the
principles and processes of conducting rehabilitation-biomedical engineering R&D within a VA environment.
These objectives will be accomplished by active intern participation in 1) projects where they are fully engaged,
2) working with and learning from diverse, engaged VA researchers at various stages in their careers, and 3) a
series of didactic training, and professional activities that sustain close interactions with VA clinical and
engineering investigators, and technical and clinical staff. Intern projects will encompass R&D in the areas of
rehabilitation engineering, assistive technology, medical devices, data analytics, and robotics. Aside from
working on their mentored R&D projects they will be exposed to different aspects of VA engineering R&D
conducted within HERL by participating in lectures and workshops. An interactive workshop involving related
industry, community leaders, advocacy organizations, veteran organizations, R&D, and graduate study
representatives will provide an opportunity for interns to learn about VA R&D career opportunities. The VALOR
intern deliverables include an elevator pitch competition, a conference formatted paper and formal poster
presentation of their work at an Intern R&D Symposium (IRS) and HERL Open House (HOH) which showcases
R&D conducted by interns. Our experienced team of mentors will adjust the level of mentoring needed to
exercise the interns’ critical thinking ability and enable VALOR interns to assume ‘ownership’ of their project.
Each intern will exercise their communication skills by interacting with members of a convergence team. A key
component of the VALOR program will be that interns learn-by-doing working intimately with the end-users to
seek solutions or to describe underlying phenomena using engineering principles and practices. Mentors and
VALOR interns will meet daily to discuss project tasks and track progress; most will work side-by-side. Interns
will be encouraged to seek the advice or assistance of their primary mentors and other team members as often
as needed. HERL engineers, technicians, and R&D staff will work with the interns to train them on the specific
skills necessary to complete their projects. Formative and summative assessments will be completed at several
phases of the VALOR program: recruitment, internship training, and post-internship follow-up. With the VALOR
program we propose to formalize and encourage replication by collecting and disseminating assessment and
outcome data.

Public health relevance
People with disabilities and veterans are underrepresented in undergraduate education leading to underrepresentation in the STEM workforce. The Human Engineering Research Laboratories (HERL) initiatives facilitate groundbreaking advancements in rehabilitation engineering (RE) and medical device design (MDD) and foster an environment ripe for educational growth. Recognizing the pressing need for diversity within engineering, HERL offers opportunities for interns to delve into RE and MDD, fields where diverse perspectives are paramount. Infusing the VALOR (Veterans Affairs Learning Opportunities in Research) program with voice of the consumer science ensures relevance and instills the principles of person-centered R&D methodologies. VALOR participants will be equipped with the invaluable ability to not only understand "how to" approach engineering challenges but also articulate "what is" from a scientific standpoint. This dual perspective not only enriches their educational journey but also empowers them to make tangible contributions.